Analysis of BRCA1 recombination functions

DESCRIPTION (provided by applicant): The long-term objective of this proposal is to determine the tumor suppressor functions of the hereditary breast/ovarian cancer susceptibility gene, BRCA1. BRCA1 and its associated proteins are known to contribute to homologous recombination (HR), a potentially error-free form of double strand break repair. However, the precise steps in HR that are regulated by BRCA1 are not well understood. Nor is it understood to what extent BRCA1's role in HR accounts for its function as a tumor suppressor gene. We propose that BRCA1 acts as a tumor suppressor by controlling sister chromatid recombination (SCR), an HR process that operates during S and G2 phases of the cell cycle to repair replication-associated DNA damage in an error free manner. To test this hypothesis, we have developed novel SCR reporters that deliver an unprecedented degree of detailed molecular information regarding SCR, and will use them to study BRCA1's role in this process. Our data suggest that cells lacking wild-type BRCA1 have a specific defect in SCR. In work proposed here, we will explore this observation in depth and attempt to relate it to BRCA1's function as a tumor suppressor. Our specific aims are: 1. To define SCR functions of BRCA1. 2. To determine whether clinically described mutant BRCA1 alleles are defective for SCR control. 3. To identify steps during DSB processing and SCR that are regulated by BRCA1.

Public health relevance
Project Narrative If a woman inherits an error in a vital anti-cancer gene, BRCA1, she will have a greatly (~10-fold) increased risk of breast and ovarian cancer throughout her life; however, we do not understand precisely how the loss of BRCA1 function leads to cancer. New discoveries in our laboratory suggest that BRCA1 is needed for a process called "sister chromatid recombination" - a way of accurately repairing DNA breaks that arise as cells grow and divide. In this proposal, we will conduct experiments to find out whether BRCA1's tumor suppressor function is linked to its ability to repair broken DNA by sister chromatid recombination.